Targeting Early Drivers of Prostate Cancer Lineage Plasticity

Lineage plasticity (LP)—most commonly exemplified by loss of androgen receptor (AR) signaling and
switch from a luminal to an alternate differentiation program—is now recognized as a critical determinant of
lethality. Most efforts in the field are focused on factors that promote terminal differentiation of specific LP
subtypes such as neuroendocrine prostate cancer (NEPC). However, LP is a continuum, ranging from AR
activity-low tumors with persistent AR expression but low AR signaling to those with alternate differentiation
programs. Factors involved in the initiation and progression of LP have not been identified. The clarification of
such factors is essential because there are no effective therapies for prostate tumors that have undergone LP.
In this proposal we seek to target key factors involved in early LP events to prevent LP from occurring.
Using an integrative genomic analysis of metastatic castration-resistant prostate cancer patient biopsies,
we determined that key transcriptional regulators are upregulated early on in the LP continuum in AR activity-
low tumors and that these factors progressively increase in terminally differentiated LP subtypes. Importantly,
gain of function studies of these transcriptional regulators in AR-driven tumors and loss of function studies in
tumors representing the continuum of LP demonstrate that these regulators block AR signaling and cooperate
with other factors to promote specific alternate differentiation programs. Targeting these transcriptional
regulators or their key epigenetic cofactors reduces survival of LP tumor cells in vitro and in vivo with good
animal tolerability, strongly suggesting we have a promising approach to block LP.
We hypothesize that key transcriptional regulators we have identified are early drivers of LP that control
prostate cancer cell fate decisions by: 1) repressing AR signaling and luminal differentiation and 2) activating
alternate differentiation programs in concert with key cofactors.
Aim 1: Determine mechanisms by which key transcriptional regulators modulate differentiation state
and cancer hallmarks. Completion of this aim will provide a detailed understanding of how key transcriptional
regulators block epithelial differentiation and activate alternate differentiation programs so we can prevent this.
Aim 2: Determine mechanisms by which key transcriptional regulators are upregulated in human
tumors. Completion of this aim will determine how key transcriptional regulators are upregulated as tumors
undergo LP and determine the association between upregulation of these regulators and patient outcomes.
Aim 3: Target key transcriptional regulators in vivo and determine the effect on LP and other
hallmarks. Completion of this aim will identify response biomarkers, measure safety, and provide the rationale
to test the combination in future clinical trials focused on patients with tumors across the LP continuum.
We expect the proposed studies will clarify the function of a network that is critical for prostate cancer
lineage plasticity, so we may translate new strategies to block this network to the clinic in the near-term.

Public health relevance
Project Narrative The factors acting early on to promote prostate cancer lineage plasticity are currently wholly unknown, and there are no effective therapies for prostate tumors that have undergone lineage plasticity. In this proposal, we will rigorously evaluate the important role of key transcriptional regulators as early drivers of prostate cancer lineage plasticity.